Institutional Research and Academic Career Development Awards (IRACDA) - UNC Postdoctoral Fellowship Program

Project Summary/Abstract.
The IRACDA-UNC program proposes to continue its 22+ year history by partnering with 4 institutions in
North Carolina to provide specialized research and academic career development training for
postdoctoral scholars. Each of the 4 partner institutions has an historical mission to educate students
from backgrounds underrepresented in the biomedical sciences (North Carolina Central University,
North Carolina A&T State University; UNC Pembroke and Johnson C Smith University). Through these
partnerships, the IRACDA-UNC program will a) provide rigorous research and teaching training for a
diverse group of postdoctoral scholars in the STEM disciplines b) develop the professional, mentorship,
and management skills needed for scholars to transition into independent academic careers, and c)
enrich the undergraduate teaching and mentoring environment at the partner institutions. Specific Aim
1 provides cutting edge postdoctoral research training within laboratories on the UNC-CH campus with
emphasis on the development of innovative research ideas, manuscript preparation, laboratory
management, and grant writing. Specific Aim 2 provides an in-depth teaching experience that includes
the latest advances in classroom pedagogical techniques, including the development of CUREs
(Classroom-based Undergraduate Research Experiences) and inclusive teaching practices. In
addition, the IRACDA-UNC program will expand the scholars’ career development with a curriculum,
Scientists Promoting Anti-Racist Conversations and Equity SPACE, which provides training in inclusive,
safe, and supportive teaching and learning environments. Specific Aim 3 provides each scholar with
extensive experience mentoring students in research projects while strengthening the research and
teaching/mentoring missions at our partner institutions. IRACDA-UNC will organize virtual research
symposia that highlight topics of common interest to our partner institutions and to UNC-CH’s biomedical
laboratories. The scholars’ training as research mentors will also be enhanced through two opportunities
that simultaneously enrich the research training for STEM undergraduates at the partner institutions.
First, scholars will mentor in our Summer Research Program, which brings undergraduate students from
the partner universities to UNC’s research laboratories. Second, IRACDA-UNC scholars will have the
opportunity to co-mentor with a faculty member of the partner institution an undergraduate’s honors (or
independent study) research project. The program proposes a steady state of 12 scholars, with 4 new
scholars admitted to the program each year. Scholars will be appointed for 3 years, with a 4th year of
support available within their research mentors’ laboratories. Upon completion of the program, scholars
are well prepared for academic positions at a range of institutions, including research-intensive and
primarily undergraduate institutions (PUIs).

Public health relevance
Project Narrative The proportion of advanced degrees awarded to underrepresented groups in the biomedical sciences continues to be very small and does not reflect the current demographics in the US. To address this shortage, the IRACDA-UNC program provides training in research, teaching, and mentoring, along with professional development that prepares postdoctoral scholars to advance science education and inspire a full range of students, particularly those from underrepresented groups, to pursue careers in the sciences.